Xenobiotic-responsive hepatic long non-coding RNAs

Diversity Supplement Application – ES024421, Waxman DJ, PI
Project Summary/Abstract - This application is for a Research Supplement to Promote
Diversity in Health-Related Research (PA-21-071) in support of a qualified underrepresented
minority PhD student who will receive graduate level training in molecular environmental
toxicology under parent grant, ES024421. The proposed training and mentoring program will
use the mouse model to advance our understanding of the interactions of nuclear receptors
when activated by foreign, environmental chemicals, with exposure to high fat dietary
regimens, with a focus on interactions that impact the development and progression of fatty
liver disease. These studies are closely related to, and will significantly advance progress
under the parent grant, and will provide the qualified underrepresented minority PhD student
with training and experience in a broad range of wet lab experimental, data analysis and
bioinformatics techniques to address cutting edge research problems in molecular
environmental toxicology.

Public health relevance
Diversity Supplement Application – ES024421, Waxman DJ, PI Project Narrative – This project provides graduate level research training and mentoring in molecular environmental toxicology for a qualified underrepresented minority student who will gain expertise in studying biological processes that occur in the liver and that impact important physiological and pathophysiological processes and disease risk.